Sex dependent effects of prolactin receptor on muscle hypersensitivity following ischemic insult

PROJECT SUMMARY/ABSTRACT: Chronic musculoskeletal (MSK) pain is leading contributor to disability.
Many conditions that cause MSK pain have a higher prevalence in females. Females often report heightened
sensitivity and lower pain tolerance in conditions where their male counterparts do not. Ischemia with
reperfusion (I/R) injury is a common cause of MSK pain and exercise intolerance (through altered exercise
pressor reflexes (EPRs)). Repeated I/R injury is often seen in complex regional pain syndrome and
fibromyalgia, both of which have higher prevalence and prolonged pain in females compared to males. Clinical
and preclinical research have linked sex hormones to pain. Prolactin (PRL) and the Prolactin receptor (Prlr)
play a prominent role in inflammatory pain in females through dorsal root ganglia (DRGs) neuron sensitization.
However, it is not yet known what roles PRL and Prlr play in ischemic myalgia. Pilot data demonstrated that
prolonged behavioral hypersensitivity in females with repeated I/R correlates with upregulation in STAT3,
TRPV1 and IL1R1 mRNA in the DRGs, while males show different transcriptional mechanisms. This may be
due to sex-specific activation of AU-rich element RNA binding protein 1 (AUF1) in female DRGs. AUF1
regulates I/R-related behaviors and IL1r1 and TRPV1 expression and is known to be modulated by STAT3.
Finally, Prlr antagonists not only inhibited female pain-like behaviors after I/R, but they also blocked the
upregulation of STAT3, IL1r1, TRPV1 and AUF1. Therefore, we will test the central hypothesis that
prolactin receptor modulates prolonged hypersensitivity following repeated ischemic injury in a sex-
dependent manner. Transgenic and pharmacological approaches will be used to determine effects of Prlr on
nociception and cardiovascular reflexes through specific neuronal subpopulations following repeated ischemic
injury in males and females. Pain-related behavioral assays, EPR tests, ex vivo forepaw muscle/median and
ulnar nerves/DRG/spinal cord single unit electrophysiological recording preparations, and molecular analyses
(realtime PCR and RNA-Seq) of DRGs will be conducted. Aim 1 will determine the neuronal subtypes
containing Prlr that modulate hypersensitivity after repeated I/R injury through knockout (KO) of Prlr in
TRPV1+ sensory neurons. Aim 2 will determine the transcriptional mechanisms within sensory neurons
that modulate prolonged hypersensitivity following repeated I/R injury and test the working hypothesis
that neuronal (TRPV1+ vs all sensory neurons) STAT3, downstream of Prlr, regulates pain-like behaviors and
EPRs after repeated I/R injury in females through activation of AUF1. This research will be the first to assess
the sex-dependent role of Prlr in MSK pain and will provide some of the first evidence to support development
of sex-based, treatment strategies for ischemic myalgia.

Public health relevance
Project Narrative The proposed research is relevant to public health because it identifies sex differences and potential sex- specific therapeutic targets that will impact the clinical care of patients with musculoskeletal pain. This innovative proposal will explore the underlying mechanisms that differentially effect females and males with ischemic muscle pain. This project is aligned with the priority of the NIH Federal Pain Research Strategy to “Elucidate Sex-Specific Pain Mechanisms and Determine their Implications for Optimal Treatment of Pain in Females and Males.”